Pacific Computational Genomics and Data Sciences Research Education Program

Project Summary/Abstract
The overarching goal of this University of Hawaii Pacific CGDS Program is to support educational activities that
encourage and promote diverse and underrepresented students to pursue studies and careers in computational
genomics and data science (CGDS) research in various fields of biomedical and behavioral sciences, hence
broadening the desperately needed educational opportunities in Hawaii and wider Pacific regions. To do that,
we will develop undergraduate and Master’s degree-level educational curricula and content in CGDS. With
longstanding experiences of training a body of underrepresented students from diverse backgrounds, our faculty
will develop and evaluate curriculum and method contents for essential and advanced CGDS research training.
We will leverage the resources of NIH cloud computing platforms to develop, implement, and evaluate classroom
educational content and cloud-based hands-on analytical exercises in CGDS. And we will make use of
educational support resources developed by the CGDS Educational Hub and partner Sites. We will facilitate
hands-on exposure to CGDS at the undergraduate and master’s degree levels among students enrolled at
University of Hawaii System and wider Pacific institutions with a mission to educate students from any
populations identified as underrepresented in biomedical research. In the Pacific CGDS Program, we will: 1)
Develop and test undergraduate and master’s levels CGDS curricula that make use of NHGRI’s AnVIL platform
and other NIH datasets and cloud-computing resources. Example contents cover the wide ranges of genomics,
transcriptomics, epigenomics, and medical and health data analyses. 2) Share these curricula for use by
biomedical and CGDS education communities, and interact with CGDS Hub and Sites for greater benefits of
research education training; 3) Develop and execute student research projects in CGDS that are orientated to
human health and diseases such as cancer, diabetes, cardiovascular disease, and minority health, as these are
the leading causes of deaths and significant health disparities. We will disseminate all the developed CGDS
curricula and methods to the broadest possible audience by leveraging our expertise in online and scalable in-
person education. Thus, this program will dramatically expand the diverse CGDS workforce in the underserved
Hawaii Pacific regions and beyond. It broadens the opportunities for CGDS education and speeds up the
adoption and use of cloud-enhanced CGDS throughout the research enterprise to tackle critical health problems
among common public and underrepresented groups.

Public health relevance
Project Narrative This program is aimed to develop, implement and share undergraduate- and Master’s-level curricula and methods in computational genomics and data science (CGDS) education and research, and interact with the community scientists and members of CGDS Educational Hub. The project will create CGDS curricula with a focus on the utility of NIH cloud resources for biomedical research and education. This program will serve the diverse and underrepresented students and scientific community members to improve knowledge and applications of CGDS.